Advanced Analytics Core

ADVANCED ANALYTICS CORE
PROJECT SUMMARY
The Advanced Analytics (AA) Core provides two classes of advanced analytics services: Bulk/single cell
genomics and EpCultures, which are 3D organoid or planar cultures derived from the intestines of human
donors or model organisms. These services are sophisticated in nature, challenging and expensive for
laboratories to independently perform, and require a high level of technical training. The AA Core has always
focused on developing innovative practices to reduce barriers of entry to these cutting-edge technologies. .
The AA Core continues to provide popular histology services, which are critical supporting technologies for in
situ validation of the genomics/spatial transcriptomics and EpCulture services. While seemingly disparate, the
services have been grouped together because of common management expertise, consultation practices, and
efficient business model practices. The core provides services at substantially reduced costs and very rapid
turnaround times. The AA Core is under the direction of Scott Magness, PhD, who is considered a leader in
single-cell genomics, single-cell functional assays, and organoid technologies. He has broad expertise in
intestinal and colonic 3D organoid and self-renewing monolayer cultures using primary tissue sources derived
from humans and other model organisms. Heather McCauley, PhD, will serve as the co-director. Dr. McCauley
is a new addition to the scientific expertise and management team. She is considered a leader in human
intestinal organoids derived from induced pluripotent stem cells (iPSCs), intestinal stem cell biology and
physiology, and humanized mouse models of the GI tract. The AA Core personnel are highly trained
professionals in these technically demanding methods and have made the AA Core nationally recognized for
single-cell sequencing services. The Specific Aims of the AA Core are: 1) To offer state-of-the-art single cell
isolation and single- and bulk-cell transcriptomic/genomic assays. These services will enable
investigators to study disease processes and gut regeneration & repair with unprecedented sensitivity and
resolution. 2) To offer services related to organoid and epithelial monolayer cultures (EpCultures), custom
EpCulture assays, intestinal stem cell gene editing, and training in EpCultures. These services will
provide investigators with physiologically relevant epithelial culture systems to model diseases and injury of the
gut lining and democratize the technologies by training the GI community scientists in these powerful methods.